Development of a DISE-inducing, short RNA therapeutic to treat ovarian cancer

PROJECT SUMMARY
Existing targeted cancer therapies have failed to produce a cure for any solid cancer. Checkpoint inhibitor
immunotherapies are curative for only a small percentage of melanoma patients (<15%) and have significant
side effects that reduce patients’ quality of life. Ideally, new therapeutics should either cure cancers or enable
their management as chronic diseases. The goal of this Fast-Track STTR project is to continue the development
of a novel, safe cancer therapy that works across cancer indications and cannot be overcome by mechanisms
of resistance. NUAgo Therapeutics’ innovation is based on groundbreaking research at Northwestern University
that has identified a new evolutionarily conserved RNA interference (RNAi)-based form of cell death that targets
survival genes (Death Induced by Survival gene Elimination, or DISE). DISE is effective against all cancers
tested to date. Importantly, the nature of the DISE mechanism means that cancer cells cannot become resistant
to the therapy, and it does not affect normal tissues. The investigators have designed and validated a novel class
of short interfering RNAs (termed “sRNAs” to distinguish them from traditional siRNAs) that target dozens of
mRNAs encoding cell survival proteins in a microRNA (miRNA)-like fashion. Each sRNA silences many targets
in multiple survival pathways, eliminating treatment resistance arising from mutations or alternative pathway
selection. Importantly, naturally occurring miRNAs out-compete these sRNAs in normal cells, preventing sRNAs
from binding to Argonaute proteins and loading into the RNA-induced silencing complex (RISC). However,
miRNA expression is globally downregulated in cancer cells, allowing our therapeutic sRNAs to promote cancer
cell death. Preliminary data show that sRNAs delivered systemically via lipid polyplexed nanoparticles (LPP) limit
tumor growth in murine and rat cancer models and kill cancer cells derived from human ovarian, prostate, and
liver cancer, with no observed toxicity to normal cells. This Fast-Track project focuses on the preclinical
requirements to develop NUAgo Therapeutics’ first sRNA (sG5C) formulated as LPPs (“NU001”) as a therapy
for ovarian cancer, where there is a high need due to rapidly emerging resistance to existing therapies.
Successful completion of the aims will optimize sG5C delivery and provide necessary preclinical data to
successfully achieve Investigational New Drug status. In Phase I, we will evaluate the in vivo efficacy of sG5C-
LPP in platinum-resistant OC xenografts and PDX models of HGSOC. In Phase II Aim 2, we will assess the
cancer selectivity and in vivo efficacy of sG5C-LPP in a murine model of ovarian cancer. Aim 3 work will develop
a stable NU001 formulation that can be used in subsequent IND-enabling in vivo studies. Aim 4 work will study
the absorption, distribution, metabolism, and excretion of NU001 separately administered by the intraperitoneal
and intravenous routes to provide key data for an eventual IND submission.

Public health relevance
PROJECT NARRATIVE Ovarian cancer has a high mortality rate, and existing treatments are plagued by the eventual development of resistance to platinum-based drugs. NUAgo Therapeutics is developing a novel RNA-interference-based therapeutic, delivered via lipid polyplexed nanoparticles, that targets networks of cell survival genes, is cancer- cell-selective, and is effective in killing cancer cells. In collaboration with Northwestern University, the company will complete key development work to support regulatory approval in this project, with the goal of bringing to market a new and more effective therapeutic option with fewer and less severe side effects for patients with high- grade serous ovarian cancer and expanding the application of this therapeutic approach to treat other cancers in the future.